Administrative Core

The Administrative Core (AC) for MT INBRE IV assures that the components of the program work together
efficiently by continually and carefully monitoring their activities and facilitating communications among them.
Specifically, the AC is responsible for allocating and overseeing all MT INBRE IV resources; establishing and
maintaining partnerships as well as the program's interactions with the External Advisory Committee (EAC),
Council, Steering Committee (SC), research projects, and cores; scheduling meetings and other activities
essential to the success of the program; selecting key personnel and the research projects conducted within
MT INBRE IV; evaluating research progress and mentoring project leaders (PLs); and overseeing all other
program activities. The paramount responsibility of the AC is to ensure that MT INBRE IV keeps its efforts
focused on the goals of the program, which are to 1) maintain and further develop the Montana research
network and student pipeline and 2) utilize this network to address serious health disparities that Montana's
rural and Native communities face. To realize these goals and accomplish MT INBRE IV's overall aims, the AC
will achieve four Specific Aims. Aim 1: Maintain and further develop the MT INBRE IV Leadership Team. Aim
2: Continue to develop the student pipeline across the Network by offering K-12, undergraduate, and graduate
student research opportunities. Aim 3: Build and enhance the Network by supporting faculty and postdoctoral
recruitment packages and providing opportunities for career development through networking at annual
network, regional and national IDeA conferences and the network's speaker series. Aim 4: Enhance
evaluation of our overall program, its individual components, and the activities within those components.